Approaches for genetic manipulation of Naegleria fowleri

Project Summary
The goal of this proposal is to develop molecular tools and approaches for the study of the
pathogenic free-living amoeba Naegleria fowleri. These currently do not exist. This amoeba
is the causative agent of primary amebic meningoencephalitis (PAM), an almost invariable
lethal brain infection. The lack of useful drugs for the treatment of this infection emphasizes
the need to develop better therapeutic agents for amoebae infections. The lack of
understanding of gene function in the parasite remains a major hurdle in target-based drug
development campaigns. Here, we propose to address this problem by developing
approaches for gene silencing and ablation by RNAi and CRISP/Cas9-mediate gene editing
and transgene expression. These approaches will serve as an important first step in
understanding both gene function and essentiality, key to early-stage drug discovery efforts.

Public health relevance
PROJECT NARRATIVE The work proposed here will yield molecular approaches and tools for manipulation of gene expression in the pathogenic free-living amoebae Naegleria fowleri. Approaches to be developed include those required for gene silencing, gene editing, and transgene expression. The work proposed will provide essential tools for resolving fundamental parasite pathobiology and will also be critical for drug discovery campaigns.